Mechanotransduction in gastrointestinal physiology

PROJECT SUMMARY/ABSTRACT
Disruptions in mechanosensation are commonly responsible for symptoms in diseases of gut-brain interaction
(DGBI), like irritable bowel syndrome (IBS), which affect ~15% of the US population. Therefore, my laboratory’s
long-term goal is to elucidate the cellular and molecular mechanisms of gastrointestinal (GI) mechanosensitivity
in health and in DGBIs.
There are several mechanosensory pathways in the GI tract. One such important mechanosensory pathway that
is involved in DGBIs is initiated through the specialized sensory epithelial enteroendocrine cells (EECs). Upon
stimulation, EECs release diverse signaling molecules that have a range of physiologic effects, and disruption
in this signaling is involved in DGBIs. We discovered an EECs sub-population which is mechanosensitive. These
EECs express Piezo2, a mechano-gated ion channel that connects forces to release of EEC signaling molecules
and endows the intestine with an ability to sense small luminal forces to adjust GI motility and secretion.
The objective of this proposal, based on strong rationale and extensive preliminary data, is to test the hypothesis
that rectal Piezo2+ mechanosensitive EECs co-express select GPCRs sensitive to digestive metabolites, which
modulate Piezo2 mechanosensitivity. These rectal mechanosensitive EECs connect chemo- and mechano-
signaling in rectal EECs, and thereby regulate regional and proximal intestinal motility. We have established
novel transgenic mouse models that allow us to lineage track, stimulate, and interrogate specific EEC sub-
populations, and we will use these mouse models and validated EEC lines with a range of innovative and
established gold-standard approaches from single cells to in vivo to study mechanosensitive EECs and their
roles in GI physiology. Aim 1 will determine the cellular mechanisms of chemo- and mechano-signaling in EECs.
Aim 2 will determine how the mechanosensitive EECs stimulated by forces and luminal digestive metabolite to
modulate GI motility.
The proposed experiments are foundationally linked to our previous work, but they represent a new and exciting
direction and can be completed in the defined award period. The results from this study are important because
they will allow us to deeply understand mechanosensitive EEC cellular physiology and their roles in GI motility,
which will enable us to examine alterations in disease, and then potentially target these pharmacologically as
novel and specific therapies for DGBIs.

Public health relevance
PROJECT NARRATIVE Disorders of gut brain interaction (DGBIs), like irritable bowel syndrome (IBS), functional dyspepsia, chronic diarrhea, and constipation, affect ~15% of the US population and lead to substantial chronic healthcare consumption and productivity losses, with costs estimated at $20 billion per year. A large proportion of DGBI patients have disruptions in mechanosensitivity; therefore, my laboratory's long-term goal is to elucidate the cellular and molecular mechanisms of gastrointestinal (GI) mechanosensitivity in health and DGBIs, and thus pave the way for novel targeted treatments for large cohorts of DGBI patients. We discovered a population of mechanosensitive enteroendocrine cells, which are important sensors in gut lining, and the objective of this proposal is to better understand their cellular function and roles in GI physiology, which would have substantial public health relevance since the knowledge acquired from these studies may yield novel diagnostic and therapeutic targets for DGBIs.